Administrative Supplement for a Fluorescence Microscope

NOT-GM-22-017 03-01-2023
Replacement of the fluorescence microscope is requested for the current R01 with NIGMS (2 R01
GM098629-10A1). The grant is active and enters its third year of funding on 04/01/2023. The
grant will be active for two years beyond the date of the request. This is a one-time request to
replace an essential piece of broken equipment. The equipment is not otherwise readily available,
and the new equipment will facilitate data gathering and successful completion of the aims.

Public health relevance
NARRATIVE Signaling pathways control cell differentiation and other responses through a common set of proteins, such as the evolutionarily conserved Rho GTPase, Cdc42. Here, we explore the regulation of Cdc42, specifically turnover, interaction with an adaptor, called Smg GDS, and regulation by mucin to identify pathway-specific effects on signaling. Replacement of our broken microscope is a necessary aspect of gaining insights into pathway-specific determinants of Cdc42 function.